Health of the Cholinergic System and Risk for Alzheimer's Disease in Postmenopausal Women

Women are at increased risk for Alzheimer’s disease (AD). Notably at menopause, some women experience
a change in cognition. However, not all women experience negative effects of menopause on cognition. The
cognitive changes that occur at menopause have not yet been connected to late life risk for pathological aging
including AD. Thus, understanding the neurobiological factors related to individual differences in cognition at
menopause is critical for understanding normal cognitive aging and for determining risk for pathological aging.
The challenge in understanding the role of estrogen loss on the risk for AD is the long lag time between the
hormonal changes at menopause and the clinical manifestations of AD. Thus, identifying how the hormone
changes after menopause are related to AD risk will alter the risk calculus for postmenopausal women in the
future.
The novel study proposed here will examine an established AD-related neurotransmitter-based mechanism
that may also underlie cognitive changes after menopause. We propose that the change in the hormonal milieu
at menopause interacts with the cholinergic system and other brain pathologies to influence a woman’s risk for
cognitive decline. Preclinical studies have shown that estrogen is necessary for normal cholinergic functioning
and its withdrawal leads to cholinergic dysfunction and cognitive impairment. It is important to determine whether
menopause-related cognitive changes correlate with both cholinergic functional integrity and established AD
biomarkers that portend increased risk for late-life cognitive impairment or dementia. This study will examine
brain functioning following cholinergic blockade to separate individuals into those who are able to compensate
for the hormone change after menopause and those who are not. We hypothesize women with poor
compensation have increased sensitivity to cholinergic blockade by showing poor performance on a cognitive
task, altered brain activation, and decreased basal forebrain cholinergic system (BFCS) volume. These
cholinergic markers will be related to menopausal factors associated with poor cognition and biomarkers of AD.
Specific Aim 1 is to examine cholinergic functional “integrity” by measuring working memory performance,
functional brain activation, and BFCS structure in postmenopausal women. Specific Aim 2 will examine whether
individual differences in menopause-relevant symptoms and known AD biomarkers are related to cognition and
brain activation after anticholinergic challenge.
The public health significance of this study is that it will identify individual difference factors that are
associated with cognitive performance changes after menopause and their relationship to structural, functional,
and biomarker evidence of risk for later life cognitive dysfunction. Knowledge of these factors will serve to
advance personalized future risk-mitigation strategies for women including hormonal, medication, cognitive
remediation, etc. that will be the subject of further research.

Public health relevance
The hormonal changes at menopause may be related to normal as well as pathological cognitive aging, but how these hormonal changes affect the risk for dementia is not fully understood. The study in this application proposes that the health and integrity of the cholinergic system allows a woman to compensate for the effects of the menopausal hormone change on brain functioning but that if this system is not intact in middle age, the risk of late-life cognitive impairment increases. The results from this study will help identify individual factors and biological markers that are associated with a woman’s risk for cognitive decline after menopause.